Social Information Processing in the Vomeronasal System during Active Behavior

Project Summary/Abstract
Animals combine sensory information and prior experiences to select and adapt behavior. How the brain
supports this ability is unknown, and this question is advantageously addressed through investigations of mouse
social behavior. In mice, social behaviors are strongly coupled to the detection of well-defined chemosignals
(e.g., pheromones), are stereotypical across individuals, and are robustly modulated by an animal’s history.
These features provide an excellent framework to define behaviorally-relevant brain areas and investigate the
underlying neural mechanisms of sensory-guided, flexible behavior. Indeed, previous studies implicate the
accessory olfactory bulb (AOB) in regulating social behaviors, but technical limitations have precluded the ability
to record activity during naturalistic interactions among freely-moving conspecific partners. Thus, our
understanding of how social behavior shapes ongoing neural activity and how this activity, in turn, guides social
behavior during active behavior remains limited. This proposal incorporates several innovative experimental
strategies and technological advances to deepen our understanding of the neural dynamics and network
architectures that support social behavior. Specifically, I will first use head-mounted miniature microscopes
(“miniscopes”) to determine how social information is represented within the AOB of freely-moving mice during
prolonged interactions as animals actively engage with a range of conspecific partners and with unique
chemosignals. Next, I propose to establish the relationship between AOB activity and intermale aggression. First,
through targeted ex vivo recordings and bidirectional chemogenetic manipulations, I will establish the relationship
between functionally defined AOB neurons and aggression levels. Next, I will determine how AOB sensory
responses are affected by mating; a salient life event that promotes AOB plasticity and increases aggression in
male mice. Together, I will establish how neural activity within the AOB adapts in support of flexible behavior.
Finally, I propose to define how social information is distributed to downstream, behaviorally-relevant limbic area
targets. I will perform multi-site retrograde labeling and pathway-specific manipulations to define how the AOB
innervates downstream targets and the behavioral relevance of these pathways. Together, these experiments
will provide fundamental information of how the brain represents, modifies, and distributes social information in
support of flexible behavior. Moreover, these results will further establish the AOB and related structures as a
powerful framework to explore the neural underpinnings of complex behavior.

Public health relevance
Project Narrative Investigating the neural basis of social behavior such as mating and aggression provides a strong framework to reveal general principles of how the nervous system supports behavior. This proposal seeks to define the manner by which sensory input relating to social partners is processed and transmitted throughout the brain to guide appropriate behavior. The results of these experiments will determine broad principles of how the brain parses out and acts on social information—the comprehension of which will greatly inform our understanding of maladaptive social behaviors in humans.